Catalytic C-C Activation: A "Cut and Sew" Approach to Bridged and Fused Rings

DESCRIPTION (provided by applicant): We are engaged in the first systematic efforts to exploit catalytic ketone/unsaturated moiety coupling via C-C activation. Our objective, in the proposed funding period, is to develop a Cut and Sew strategy for the efficient synthesis of bridged/fused ring systems via catalytic C-C activation, which includes 1) regular Cut and Sew: Rh- or Co-catalyzed intramolecular carboacylation with both strained and unstrained cyclic ketones; 2) decarbonylative Cut and Sew: catalytic intramolecular couplings between cyclic ketones and unsaturated moieties with CO extrusion. The research proposed is expected to provide a general and unified strategy to build complex skeletons, found in numerous natural products and drugs, from simple starting materials.

Public health relevance
PUBLIC HEALTH RELEVANCE: Complex ring structures exist in over 60% of natural products and pharmaceutical compounds, and these scaffolds generally play key roles in their biological activity. However, chemical synthesis of these ring systems proves challenging, and current approaches need to be improved. Employing our recently developed C-C activation strategy, the outlined proposal provides rapid/general access to the core skeletons of various biologically important molecules in a catalytic and byproduct-free manner, which, in turn, would significantly expedite the synthesis of these molecules and ultimately accelerate drug discovery.